MECHANISMS OF INSULIN RESISTANCE IN CYSTIC FIBROSIS

The PI has described insulin resistance (IR) in cystic fibrosis (CF) patients, but the cause is unknown. The hypotheses are (1) that IR in CF is caused from post-insulin receptor defects in glucose transporter translocation (GLUT4), and (2) that IR will be correlated with high levels of acute phase reactants such as TNF-alpha. In CF patients and controls, the PI will measure GLUT4 translocation from vastus lateralis; 24 cortisol, growth hormone and catecholamines; and TNF-alpha, C-reative protein and other acute phase reactants. The investigators found that a) when compared to controls, CF patients have decreased translocation of GLUT4; b) CF patients have higher levels of TNF-alpha. There is no difference between controls and CF patients for cortisol, IL-6 and IL-1.